Dartmouth Training Program in Quantitative Cancer Research

ABSTRACT
Continued support is requested for a multidisciplinary Dartmouth Training Program in Quantitative Cancer
Research (TQCR). The TQCR Program seeks to provide cross-training in quantitative, computational, and
biomedical sciences to prepare students for the emergent cancer research landscape that is increasingly
characterized by complex problems, big data, and multidisciplinary teams. At Dartmouth, the TQCR Program
will enlist graduate student trainees from different academic backgrounds, including computer science,
mathematics, biology, chemistry, and engineering who are committed to cancer-centered research activities with
a strong quantitative component. These graduate student candidates for TQCR support will be recruited broadly
from cancer-focused research laboratories across four graduate programs at Dartmouth: The Geisel School of
Medicine’s Molecular & Cellular Biology and Quantitative Biomedical Sciences PhD Programs, The Thayer
School of Engineering’s PhD program, and The School of Arts and Sciences Computer Science PhD Program.
Faculty mentors include quantitative scientists with significant extramural funding and a strong track records of
graduate training experience and biomedical research. Research areas of the faculty include quantitative
methodology and scientific applications in bioinformatics, biostatistics, computer science, computational biology,
genomics, and epidemiology. Selected TQCR students will engage in a cancer-specific, quantitative curriculum
that includes courses in computer science, bioinformatics, biostatistics, epidemiology, cancer biology and
integrative biomedical sciences, exposing them to both interdisciplinary research and quantitative methodology
development over the course of a 2-year fellowship period. This reflects our institution’s long history of
exceptionally strong cancer research and clinical programs, largely based on the success of our comprehensive,
NCI-designated Norris Cotton Cancer Center. It is our vision that the next generation of quantitative researchers
requires comprehensive interdisciplinary training to contribute meaningfully to future progress in understanding,
preventing, and treating cancer.

Public health relevance
NARRATIVE Support is requested for a multidisciplinary predoctoral Dartmouth Training program in Quantitative Cancer Research. It is our vision that the next generation of quantitative researchers will require skills and expertise from areas such as bioinformatics, biostatistics, and epidemiology to tackle the most challenging problems in future cancer research.